Carboplatin or Olaparib for BRcA deficient prostate cancer (COBRA)

Abstract
Advanced prostate cancer is a universally lethal disease and one for which no biomarkers have yet been found
to inform therapeutic decision making. DNA repair deficiency in the homologous recombination pathway
increases sensitivity of tumors to DNA damaging agents for patients with breast and ovarian cancers. Early
data suggests that the DNA damaging agent carboplatin may be exceptionally effective in DNA repair deficient
prostate cancer. This study would determine if the use of the DNA damaging agent carboplatin is more
effective than docetaxel in homologous recombination deficient prostate cancers in the first line setting and
compare responsiveness to the alternate drug at crossover. The proposed study is a randomized phase II
study of first line carboplatin vs. docetaxel in men with metastatic, castration resistant prostate cancer
containing BRCA1 or BRCA2 or PALB2 mutations after prior therapy with abiraterone and/or enzalutamide and
for whom chemotherapy is considered appropriate. Patients will be treated with first line therapy until
progression, intolerance or 10 cycles. At the time of progression, patients will cross over to the alternative
regimen. The primary endpoint will be progression free survival with the first line therapy (PFS-1L) with
secondary endpoints of progression free survival with second line therapy (PFS-2L) and PFS to both therapies
combined as well as toxicity of each regimen. This study will provide critical information regarding efficacy and
toxicity of carboplatin vs. the standard of care chemotherapy and whether use of DNA targeting agents initially
will provide longer PFS than first line docetaxel. The importance of this study will be to establish the utility of
BRCA and PALB2 as predictive biomarkers for carboplatin and to determine if carboplatin alone is an effective
and safe therapy in men with resistant prostate cancer. The study would also establish whether carboplatin is
appropriate to test in future studies against other agents targeting DNA repair pathway deficiency such as
poly(ADP-ribose)polymerase inhibitors (PARPi). PARPi are very effective in early studies but are expensive
and can be toxic. If this study demonstrates efficacy of carboplatin, randomized cost effectiveness studies vs.
PARPi within the VA would be justified.

Public health relevance
Relevance Prostate cancer is the leading cause of cancer related death in veterans. Although significant progress has been made in treatment, “exceptional responses” are rare and there is currently no way to personalize care for men with this disease. This study will test the effectiveness of carboplatin, a drug with early evidence for exceptional responses and lower toxicity, against the standard of care chemotherapy drug in veterans with specific mutations in their cancer which would predict for effectiveness. If successful, this study could provide a means of predicting which veterans could benefit from more effective and less toxic therapy for metastatic, resistant prostate cancer.